Disruptions to nuclear proteostasis machinery as drivers of neurodegeneration in dementia.

PROJECT SUMMARY
A growing number of Americans over the age of 65 live with dementia. A set of devastating neurodegenerative
diseases cause dementia, including Alzheimer’s disease (AD) and frontotemporal lobar degeneration (FTLD).
Neurofibrillary tangles composed of hyperphosphorylated tau are a pathological hallmark of AD and related
tauopathy disorders including FTLD-tau. Several other pathologies also drive neurodegeneration in AD related
dementias (ADRD), including the aggregation of the RNA binding protein TDP-43 and expansion-related
polyglutamine repeat proteins (PolyQ). While the ultimate molecular mechanisms driving neurodegeneration in
AD/ADRD are poorly understood, disruptions to many aspects of nuclear homeostasis in neurons contribute to
these age-related diseases, including disruptions to nuclear pore complexes, nucleocytoplasmic transport and,
as I have helped to show, nuclear speckles and RNA processing. My published work and preliminary data now
also nominate nuclear proteostasis and nuclear ubiquitin proteasome system (UPS) machinery as novel and
shared regulators of the early pathogenesis of neurotoxic aggregates and neurodegeneration in AD, FTLD, and
Huntington’s disease, an inherited early-onset dementia.
I previously showed that genetic deletion of SPOP homolog SPOP-1 rescues significant behavioral deficits,
protein aggregation, lifespan defects, and neurodegeneration driven by the microtubule-binding protein tau in a
Caenorhabditis elegans model of tauopathy. My preliminary evidence suggests that the activity of C. elegans
SPOP-1/CUL-3 nuclear substrate BET-2, homologous to the bromodomain and extraterminal domain (BET)
family of transcription factor proteins in humans (BRD2, BRD3, BRD4, and BRDT), underlie these results. My
early data also show SPOP modifies TDP-43 and PolyQ neurotoxicity in models of AD/ADRD proteinopathy and
is translationally relevant in mammalian neurons and to human disease.
Altogether, my work has led us to hypothesize that the degradation of BRD transcription factors is a critical and
translationally relevant molecular pathway to neurodegeneration in AD/ADRD. We hypothesize disruptions to
nuclear UPS machinery and nuclear proteostasis, in general, are also key contributors to nuclear dysfunction in
early disease pathogenesis. To investigate these hypothesizes the specific aims of this project are:
SPECIFIC AIMS: (1) Determine the impact and relevance of BRD transcription factor degradation in
AD/ADRD. (2) Systematically characterize the impact of nuclear proteostasis machinery in AD/ADRD.
By completing the proposed work, we will provide further insight into the biological mechanisms underlying the
role of the CUL3/SPOP/BRD axis (F99) and, more broadly, the role of disruptions to nuclear protein homeostasis
(K00) in driving neurodegeneration in AD and diverse ADRDs.

Public health relevance
PROJECT NARRATIVE A growing number of Americans over the age of 65 live with dementia, brought on by a set of devastating neurodegenerative diseases with overlapping pathologies and symptoms, including Alzheimer’s disease (AD), frontotemporal lobar degeneration, and other AD related dementias (AD/ADRD). While the ultimate molecular mechanisms driving neurodegeneration in AD/ADRD are poorly understood, our previous work and preliminary results demonstrate disruptions to nuclear protein quality control are characteristic of AD/ADRD and that the activity of nuclear ubiquitin ligase complexes control pathological tau, TDP-43, and other protein aggregation in disease. The completion of the proposed work will provide further insight into biological mechanisms underlying the role of BRD transcription factor degradation (F99) and, more broadly, the role of disruptions to nuclear protein homeostasis (K00) in driving neurodegeneration in AD/ADRD.